A Naturalistic Examination of Dietary Lapses in Low-Income, Treatment-Seeking Families with Obesity

Project Summary/Abstract
Childhood obesity is a serious public health concern that disproportionately affects low-income youth. Although
family-based behavioral obesity treatment (FBT) is an efficacious intervention, low socioeconomic status is
associated with poor treatment adherence and suboptimal response. Elucidation of modifiable risk factors that
contribute to these treatment disparities in low-income families is crucial to maximize treatment response and
prevent chronic weight-related comorbidities in high-risk youth. One important modifiable risk factor is non-
adherence to dietary recommendations (i.e., dietary lapses), a strong predictor of obesity treatment non-
response. According to goal-conflict theory of self-regulation, dietary lapses occur due to failure to inhibit
responsiveness to momentary intrapersonal (e.g., negative emotions) and socioenvironmental (e.g., presence
of unhealthy foods) cues that undermine core self-regulatory processes involved in eating-related self-regulation.
Parents are key supporters of child eating self-regulation by modeling healthy eating habits and structuring the
family food environment. As such, it is plausible that failed attempts by the parent to self-regulate their own eating
behavior could trigger a dietary lapse in the parent and subsequently in the child, which may lead to weight gain
over time. Importantly, low-income families may be at increased risk for dietary lapses due to the salience of
intrapersonal and socioenvironmental cues in their natural environment that thwart attempts to self-regulate
eating behavior. Data show that parent-reported momentary depressed mood and stress predict unhealthy
parent feeding practices in low-income families. Further, socioenvironmental factors such as the presence and
availability of unhealthy foods and prohibitive cost of healthy foods in low-resource neighborhoods may place
additional demands on parents’ ability to select healthy foods on behalf of their child. To date, no studies have
investigated whether or how these momentary cues lead to parent dietary lapses and subsequent child dietary
lapses in low-income families, nor examined the impact of dietary lapses on parent and child weight change.
Ecological momentary assessment, an assessment tool that collects repeated measures behavioral data in real
time in the natural environment, is an ideal methodology to characterize dietary lapses given their sensitivity to
contextual triggers. Further, EMA methods may offer incremental validity over traditional self-report methods that
rely on biased retrospective recall of dietary adherence. Therefore, in a sample of 48 parent-child dyads (children
aged 5-12) recruited from an ongoing FBT trial in low-income families, the proposed study will employ EMA to
characterize the frequency, nature, and momentary context of parent dietary lapses, and examine their effects
on subsequent child dietary lapses and parent-child weight change throughout 3-month FBT. Results from the
proposed study have the potential to inform the development of novel childhood obesity interventions by
revealing precise moments to support family eating-behavior self-regulation.

Public health relevance
Project Narrative Socioeconomic disparities in childhood obesity prevalence and treatment response are well-documented and may be explained, in part, by non-adherence to dietary recommendations (i.e., dietary lapses) caused by momentary failures to regulate eating behavior. Given the salience of intrapersonal and socioenvironmental cues that thwart eating-related self-regulation in the natural environment of low income families (e.g., stress, food insecurity), the proposed study will employ a naturalistic design to characterize parent dietary lapses and explore their effects on child dietary lapses and parent-child weight change during 3-months of family-based behavioral obesity treatment. Results from this study will extend the literature on modifiable risk factors for childhood obesity in high-risk subgroups of youth and inform targets for novel intervention efforts.